Southern California Research Center for ALPD and Cirrhosis

ADMINISTRATIVE CORE - SUMMARY
The Administrative Core is the key organizational backbone for the Southern California Research Center
for Alcoholic Liver and Pancreatic Diseases (ALPD) and Cirrhosis. It plays an integral role in supporting
the center’s pursuit for the mission of serving as a national resource by achieving efficient networking
and communications among all center components and internal and external oversight committees and
providing required administrative support. The core also identifies and facilitates new programmatic
developments for research on the center theme; promotes new collaborative opportunities among the
center members and with non-center investigators; and renders coordinated efforts to support the
academic growth of graduate students, postdocs and early-stage investigators.
The Core fulfills the following specific responsibilities: 1) efficient IT-based communication among the
center components and members; 2) budgetary and financial management; 3) administrative and
logistic support to the cores; 4) coordinating biannual Executive, Pilot Project, Education/Training, and
Outreach Committee meetings, and an annual Scientific Advisory Board meeting; 5) organizing
Progress Report meetings, single-topic workshops, and annual center symposia; 6) managing
educational and training program; 7) supporting local and global outreach; and 8) fundraising and
implementation for new programmatic developments. The Core also supports optimal cross-utilization of
the unique and complementary resources available at our center, other centers of excellence,
government and non-profit organizations within and outside of our regional network.
In the past 5 years, the Core’s strategic efforts have contributed not only to the center’s scientific and
research base growth but also to the emergence of successful early career investigators, education and
training of undergraduate and graduate students, and implementation of 4 community
seminar/workshops and 4 international symposia. With support by the Administration Core, the center
continues to strive as a uniquely specialized, interdisciplinary, and integrated center of excellence
serving regional, national and global communities.